Alterations in BMP Signaling in the Aging Brain

? DESCRIPTION (provided by applicant): Aging often leads to a functional decline across multiple cognitive domains, but the physiologic and anatomic changes underlying these impairments are not fully understood. A number of changes in hippocampal structure and connectivity are associated with aging including a decline in neurogenesis in the subgranular zone of the dentate gyrus (DG) and decreased performance on hippocampus-dependent tasks. Levels of bone morphogenetic protein 4 (BMP4) in the mouse DG increase more than 10-fold between 8 and 52 weeks of age. A similar aging-related increase in BMP4 expression is found in the human DG. Conversely, levels of the BMP inhibitor, noggin, in the mouse DG decrease by about 70% during this time. This results in an extraordinary 30- fold aging-related increase in BMP signaling in the DG measured by levels of phosph-SMAD1/5/8. Reducing BMP signaling in aged mice by either intraventricular infusion or transgenic overexpression of noggin reverses aging-related changes in both neurogenesis and cognition. Conversely, transgenic overexpression or intraventricular infusion of BMP4 in aged mice prevents the beneficial effects of exercise on neurogenesis and cognitive performance. These findings lead to the hypothesis that changes in BMP signaling underlie the decreases in neurogenesis and in hippocampus-dependent behavior associated with aging. To test this hypothesis we will first investigate the cellular and behavioral effects of inducible cre-mediated ablation of BMPRII in the DG neural stem cells (NSCs) of aged mice. To identify BMP targets associated with aging related neural stem cell quiescence, we will perform genomic scale gene expression profiling of NSCs isolated from BMPRII intact and ablated aged mice. Finally, we will define changes in expression and cellular origin of BMP ligands, receptors, and inhibitors in the hippocampus of aging humans and examine correlations between BMP levels, neurogenesis, and age-associated cognitive decline in human. The goal of the studies is to identify specific molecular loci where therapeutic intervention in the aged nervous system may lead to a return to normal neurological function.

Public health relevance
PUBLIC HEALTH RELEVANCE: Aging often leads to a functional decline in cognition. We have found that there are profound alterations in a specific signaling system, BMP signaling, in the aging human and mouse brain. Reversing these changes in the aging mouse brain restores some cognitive functions. The goal of these studies is to define specific targets for drug treatment in the aged nervous system that may lead to a return to normal cognitive function